Advancing precision medicine through measurement of reward and relief drinking

Project Summary/Abstract
American Indian and Alaska Native (AIAN) communities experience significant alcohol-related problems, further
propagated by obstacles to beginning effective, high-quality treatment for alcohol use disorder (AUD). Precision
medicine approaches to AUD treatment may make treatment more efficient and effective by individually tailoring
AUD treatments to common etiological and maintenance mechanisms underlying AUD. For example, recent
precision medicine efforts have identified that individuals who drink primarily in the context of reward (i.e.,
drinking for enhancement and social interaction) may respond better to naltrexone, whereas those who drink
primarily in the context of relief (i.e., drinking to relieve negative physical and affective states) may respond better
to acamprosate. However, extant measures used to classify reward and relief drinking tendencies do not account
for the contextual factors associated with these constructs in AIAN peoples. Identifying relevant measures of
reward and relief drinking tendencies in AIAN peoples may inform precision medicine research and reduce
burden related to alcohol problems in AIAN. The proposed work will utilize a multi-method approach grounded
in a community-engaged research framework to develop a tailored measure of reward and relief drinking by
refining and expanding on several existing measures of reward and relief drinking and assess the construct
validity of the newly developed measure in AIAN peoples. First, we will recruit AIAN people with AUD (N=20) to
examine the content validity of three existing measures of reward and relief drinking and use cognitive
interviewing methods to refine existing items and/or develop additional relevant items. Second, we will administer
these items and any participant-identified additional items to a geographically varied sample (N=100) of AIAN
with AUD. Using these data, we will then examine structural validity by identifying the hierarchical contributions
of individual items to respective reward and relief drinking factors by conducting nonparametric item response
theory (IRT) analyses. Lastly, we will utilize the refined measure to identify reward and relief drinking subgroups
and examine comparative associations with convergent constructs to assess external validity. Ultimately, the
proposed research will produce a construct-valid measure of reward and relief drinking informed by the lived
experiences of AIAN peoples with AUD. The tailoring of an AIAN-specific measure of reward and relief drinking
will play a direct role in improving alcohol problems in this population.

Public health relevance
Project Narrative Precision medicine approaches to alcohol use disorder treatment have potential to more efficiently ameliorate urgent alcohol-related health problems in American Indian and Alaska Native (AIAN) peoples by matching individuals to a personalized treatment based upon reward and relief drinking mechanisms. The proposed study will engage AIAN peoples in assessing the validity of reward and relief drinking measures, develop refined scales, and examine their utility in identifying reward and relief drinking subgroups. Ultimately, the proposed work aims to understand the impact of drinking context on identification of phenotypic subgroups to improve the precision of precision medicine approaches to alcohol use treatment.